Maternal-Fetal Medicine Units (MFMU) Network

The Maternal-Fetal Medicine (MFM) Division of the University of Alabama at Birmingham (UAB) submits this
application to continue as a clinical center of the NICHD MFM Units (MFMU) Network. We present our center's
attributes and longstanding record of exceptional performance in the Network. We remain committed to the
Network's goals to improve obstetric care, pregnancy health, and outcomes for pregnant/lactating people and
their babies. Our internationally-renowned, Center for Women's Reproductive Health (CWRH), the home of our
MFMU center, has a research staff of >50 and extensive successful experience leading large clinical trials and
observational studies to transform maternal and infant health both in and outside the Network. As an MFMU
center for >30 years, UAB has consistently played a leadership role in providing stewardship for the Network at
the Steering Committee and sub-committee levels, conducted Network trials with the highest efficiency of any
center, and led all centers in the presentation and publication of data generated. Among 32 clinical centers in
MFMU history, a UAB investigator first-authored >17% of Network publications (14.5% since 2016) and 18% of
presentations at national meetings. Current members of our team have accumulated >250 MFMU person-years'
experience of active participation supporting MFMU projects; our research staff similarly cumulate >275 MFMU
person-years. Alan Tita, MD, PhD (CWRH Director) and Brian Casey, MD will continue as PI and Alternate PI,
respectively. Our team includes 2 previous MFMU PI's and 7 members who have served or currently serve as
Network protocol chairpersons or Subcommittee members. We continue to enroll and retain the highest number
of participants in many network studies; adjusted for the available population, we enroll the highest of any MFMU
site. Our enriched high-risk and diverse population (>50% black), strong culture of research support and
collaboration, 24/7 research staff coverage and high proportion of screen-eligible patients successfully enrolled
into network studies allow us to sustain and continue this high level of performance. If successful in this renewal,
we will strengthen our collaboration with Ochsner Health System as a satellite site. We will deploy our extensive
research resources - data management systems, recruitment resources including programming into electronic
health records, transdisciplinary investigative team and experienced personnel - to conceive, design and
implement new innovative and impactful studies. We will leverage the network to train future research leaders
including our next PI. Our record of success extends to leadership of complementary large non-MFMU consortia
conducting impactful clinical trials and follow-up studies towards similar goals, including the Chronic
Hypertension and Pregnancy consortium and the American Heart Association Health Equity Research Network
on Disparities in Maternal-Infant Health Outcomes. Since 2016 our core MFM investigators had >260 non-MFMU
peer-reviewed publications. We believe our center's attributes detailed herein, the sustained record of success,
and our plans to prioritize MFMU studies position us for success during the new 7-year cycle.

Public health relevance
PROJECT NARRATIVE Through renewal and active participation in this multicenter collaborative research program, UAB clinical center researchers will assist the MFMU Network in conceiving and designing new innovative studies and complete ongoing projects intended to improve obstetric care, pregnancy health, and outcomes for pregnant and lactating people and their babies. These problems include maternal mortality and morbidities related to pregnancy, labor, and post-partum recovery; preterm birth and infant mortality. Our diverse team will continue to support activities of the MFMU to address health disparities through inclusion of our racially and ethnically diverse population.